Northwestern University Clinical and Translational Science Institute (NUCATS)

Contact PD/PI: LLOYD-JONES, DONALD M
ABSTRACT. The Northwestern University Clinical and Translational Sciences Institute (NUCATS) serves as
an integrated hub to advance Clinical and Translational Science (CTS) at three distinct scales: locally, at
Northwestern University (NU) and our 3 nationally-renowned clinical partners; regionally, across Chicago and
in collaboration with the other two Chicago CTSA hubs and our many community stakeholder partners; and,
nationally, through our active participation in the CTSA Consortium. By leveraging continuous CTSA funding
since 2008, as well as substantial financial and in-kind support from NU and our partners, NUCATS has
succeeded at all three scales, evolving into a mature, balanced, highly-functioning CTSA with a broad portfolio
of leading-edge programs spanning T0 through T4. Looking to the future, we recognize that there continue to
be exciting strategic opportunities for innovation and improvement, and NUCATS is not afraid to experiment
upon itself to achieve our mission of speeding transformative research discoveries to patients and the
population, in order to improve human health. We will build on this legacy through five broad-based Global
Objectives, which focus on: expanding and further integrating research into clinical care systems and
processes, with the ultimate goal that every clinical encounter can be an opportunity for research participation,
precision medicine, and learning to improve human health for all; accelerating local, regional, and national CTS
by enhancing our existing integrated digital research infrastructure to develop and apply new, leading-edge
informatics and data science tools to catalyze research, education, collaboration, engagement, evaluation, and
dissemination; broadening our community and stakeholder engagement and advance team science to enable
high-functioning, stakeholder-engaged, multi-disciplinary research teams that have impact across the
spectrum of CTS; developing, demonstrating, disseminating, and adopting innovative and sustainable CTS
methods and processes to accelerate translation and foster a culture of rigor, reproducibility, evaluation, and
continuous improvement across the CTSA consortium; and innovating, testing, and disseminating novel
training programs to cultivate, equip, and empower the diverse translational research workforce of tomorrow.
We propose to leverage CTSA funding to address key strategic opportunities and critical barriers to CTS, not
only at NUCATS, but across Chicagoland and the CTSA consortium. In doing so, we anticipate that NUCATS
will continue be a central player in the ongoing evolution of the role of CTSA Program in accelerating CTS to
improve human health.
Page 236
Project Summary/Abstract
Contact PD/PI: LLOYD-JONES, DONALD M

Public health relevance
Project Narrative The mission of the Northwestern University Clinical and Translational Sciences (NUCATS) Institute is “to speed transformative research discoveries to patients and the population, in order to improve human health.” NUCATS serves as the hub for clinical and translational research across Northwestern University and its clinical partners, Northwestern Memorial HealthCare, Ann & Robert H. Lurie Children’s Hospital of Chicago, and the Shirley Ryan AbilityLab. In this funding period, NUCATS will build on its unique strengths to further integrate research into all aspects of clinical care, support all of our endeavors with our rich informatics and digital infrastructure, support inter-disciplinary teams that include community stakeholders evaluate and improve research methods, and train and equip the translational workforce. Page 237 Project Narrative